DEVELOP. AND PSYCHOSOC. COMPLICATIONS IN CHILDREN WITH BILIARY ATRESIA

Identifying and understanding developmental and psychosocial complications of children with biliary atresia and their families is necessary to develop goals and supportive interventions to optimize potential outcome. A prospective, longitudinal study is needed to accomplish this.